Zonal-Specific Mineralized Scaffolds for Osteochondral Regeneration

PROJECT SUMMARY/ ABSTRACT
Biomineralization is an essential process controlling the structural development and pathological progression of
several tissues and organisms. Depending on the degree of biomineralization, collagen fibers can be as
compliant as tendons and ligaments (without minerals), as rigid as bones (with abundant minerals), or have a
gradient rigidity as cartilage (with zonal-specific minerals), in the musculoskeletal system. On the other hand,
ectopic biomineralization often results in severe diseases. For instance, calcification of vascular tissues may
lead to thrombus formation or atherosclerotic lesions, while calcification of articular cartilage is a sign of
osteoarthritis (OA) progression. Therefore, it is essential to understand the mechanisms of biomineralization and
mimic the mineralization process in vitro to replicate the composition, structure, and properties of mineralized
tissues. Osteochondral (OC) tissue has a multiphasic structure consisting mainly of articular cartilage and
subchondral bone with zonal-dependent mineralization. Specifically, the intrafibrillar minerals (within collagen
fibers) and extrafibrillar minerals (on the surface of collagen fibers) constitute 85.8 wt.%, 65.1 wt.%, and 0% of
the dry weight of the subchondral bone, calcified cartilage layer, and cartilage layer, respectively. Due to this
complex structure and poor intrinsic regeneration capability, OC repair is highly challenging. Tissue engineering
approaches using multizonal scaffolds have been shown as effective alternatives for enhanced OC regeneration.
The objective of this application is to develop and evaluate a zonal-specific mineralized scaffold optimal for OC
regeneration by controlling the mineralization of collagen. The central hypothesis is that the progenitor cell-
seeded multizonal scaffold mimicking the hierarchical microstructure and composition of native OC tissue with
sustained local release of functional trace elements is a promising therapeutic option to improve OC
regeneration. To test our hypothesis, the objective of this proposal will be achieved by three specific aims: (1)
Design and fabricate individual zones with different compositions and fiber orientations by controlling biomimetic
mineralization. (2) Seamlessly bond Characterize and individual zones into monolithic multizonal scaffolds. (3)
Evaluation of in vitro osteochondral cell differentiation and in vivo osteochondral tissue formation within the
progenitor cell-loaded multizonal scaffold. The innovation lies in (1) designing highly biomimetic five-zone
scaffolds with zonal-dependent mineralization and fiber orientation. (2) for the first time, considering the
intrafibrillar and extrafibrillar features in the subchondral bone zone. (3) achieving sustained local release of
functional trace elements. (4) using chondroprogenitor cells and BMSCs harboring fluorescent reporters to
virtualize zonal-specific osteochondral differentiation in situ. This application is partially designed to create an
appropriate undergraduate training experience in biomaterials development and evaluation by advanced imaging
technologies, particularly for the first class of Biomedical Engineering students in the university’s history.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE TO PUBLIC HEALTH Biomineralization controls many processes involving structural development and disease progression of various tissues and organs, including osteochondral tissues. By establishing a better understanding of biomineralization in nature, this application will create biomimetic materials that closely replicate the zonal-specific microstructures, compositions, and properties of native joints, aiming to provide a therapeutic option for osteochondral lesions, which are one of the musculoskeletal conditions with a focal area of damage to the articular cartilage and underlying bone that affect public health.